Electron Microscopy Core Facility

The EMF assesses whether the users' goals are achievable via EM, and suggests suitable EM techniques to serve their needs. EMF Provides technical support on sample preparation, including fixation, tissue processing, sectioning, and training users on the use of microscopes. If needed, EMF will assist in interpretation of the images. The EMF in FY22 has worked with 12 PI's and more than twenty staff members from these labs, resulting in 7 publications acknowledging contributions from EMF:

1. Zhu PP, Hung HF, Batchenkova N, Nixon-Abell J, Henderson J, Zheng P, Renvois B, Pang S, Xu CS, Saalfeld S, Funke J, Xie Y, Svara F, Hess HF, Blackstone C. Transverse endoplasmic reticulum expansion in hereditary spastic paraplegia corticospinal axons. Hum Mol Genet. 2022 Mar 26:ddac072.

2. Shi B, Jin YH, Wu LG. Dynamin 1 controls vesicle size and endocytosis at hippocampal synapses. Cell Calcium. 2022 May;103:102564. doi: 10.1016/j.ceca.2022.102564. Epub 2022 Feb 18. PMID: 35220002; PMCID: PMC9009158.

3. Arpino, G., Somasundaram, A., Shin, W., Ge, L., Villareal, S., Chan, C.Y., Ashery, U., Shupliakov, O., Taraska, J.W. & Wu, L.G. Clathrin-mediated endocytosis cooperates with bulk endocytosis to generate vesicles. iScience 25, 103809 (2022).

4. Shi B, Wu XS, Cordero NP, Moreira SL, Wu LG. Light and electron microscopic imaging of synaptic vesicle endocytosis at mouse hippocampal cultures. STAR Protoc. 2022 Jun 23;3(3):101495. doi: 10.1016/j.xpro.2022.101495.

5. Shin, W., Zucker, B., Kundu, N., Lee, S.H., Shi, B., Chan, C.Y., Guo, X., Harrison, J.T., Turechek, J.M., Hinshaw, J.E., Kozlov, M.M. & Wu, L.G. Molecular mechanics underlying flat-to-round membrane budding in live secretory cells. Nat Commun 13, 3697 (2022).

6. Liu, L., Dodd, S., Hunt, R., Pothayee, N., Atanasijevic, T., Bouraoud, N., Maric, D., Moseman, E., Gossa, S., McGavern, D., and Koretsky, A. Early detection of cerebrovascular pathology and protective antiviral immunity by MRI. eLife. 2022 May 5;11:e74462.

7. Shammas MK, Huang X, Wu BP, Fessler E, Song IY, Randolph NP, Li Y, Bleck CK, Springer DA, Fratter C, Barbosa IA, Powers AF, Quirs PM, Lopez-Otin C, Jae LT, Poulton J, Narendra DP. OMA1 mediates local and global stress responses against protein misfolding in CHCHD10 mitochondrial myopathy. J Clin Invest. 2022 Jul 15;132(14):e157504.

In addition, users also presented talks in scientific meetings and seminar serieses.

The manager of EMF, Jung Hwa Tao-Cheng, presented two talks in the seminar series organized by Andy Cole/Tom Reese:
1. A hodgepodge of EM images of inhibitory synapses
2. The synaptic cleft sticks around through thick and thin

The manager of EMF also reviewed three articles (Cells, BioRxiv, Neuroscience Letters)